Developing methods for advancing the early detection of pancreatic ductal adenocarcinoma leveraging electronic medical records data

PROJECT SUMMARY
Pancreatic ductal adenocarcinoma (PDAC) is projected to become the second-most common cause of cancer-
related death in the United States. Detecting PDAC early has been challenging due to its rapid progression
and late presentation. Recent collaborative efforts among NCI, PanCAN, and NIDDK have resulted in multiple
studies utilizing electronic medical records (EMRs). They provide opportunities to advance the early detection
of PDAC, since the approach taken in the research setting is identical to what would be used in clinical practice.
Future implementation in EMRs could lead to earlier diagnostic testing or interventions, enable the rapid
identification of cancer trends or risk factors, and allow for quicker action. These studies, including our own,
have demonstrated that individuals with glycemically-defined New Onset Hyperglycemia and Diabetes (NOD)
have a significantly higher risk of being diagnosed with PDAC within 3 years of meeting diabetes mellitus
criteria. The Enriching New-Onset Diabetes for Pancreatic Cancer (ENDPAC) score further stratifies
individuals with NOD based on their PDAC risk, considering factors such as weight changes, blood glucose
levels, and age at diabetes onset. However, several challenges need to be addressed to ensure the success of
PDAC early detection. Firstly, it is important to better define the at-risk population for PDAC, as NOD alone
may not be sufficient. Individuals with new-onset prediabetes and those with worsening long-standing diabetes
mellitus may also be viable targets for early detection of PDAC. Secondly, more effective enrichment strategies
leveraging biomarkers are critical, as directly applying existing biomarkers may not yield optimal results. For
example, the ENDPAC score, which was developed primarily in a predominantly white NOD population, should
be adapted for other high-risk groups, such as individuals with NOPD, LSDM, and diverse demographic
populations to ensure broader applicability.
We will develop a comprehensive set of methods to address these challenges, aimed at identifying high-risk
populations, exploring promising biomarkers using EMR data, and integrating them with advanced biomarkers
in an efficient manner. Given the expertise of our team and the strength of our collaborative partnerships, the
advancements in methodologies, and the potential clinical applications, we anticipate that our efforts will yield
tangible clinical benefits in the near term.

Public health relevance
PROJECT NARRATIVE Detecting Pancreatic ductal adenocarcinoma (PDAC) at an early stage has been challenging due to its rapid progression. Collaborative efforts using electronic medical records (EMRs) have shown promise in advancing early PDAC detection, but challenges remain in optimally defining at-risk populations for PDAC and identifying biomarkers to effectively enrich PDAC risk. This proposal leverages the EMR platform to address these challenges, aiming to identify high-risk populations and enhance risk stratification using EMR-derived biomarkers.